Diverse visual processing properties of novel ganglion cell and amacrine cell types in the human retina

Project Summary/Abstract
The goal of our research is to understand the visual processing performed by the human retina. In the
proposed work, we will explore the striking and novel visual properties of numerous new cell types we have
recently discovered in the human retina – including more than 10 retinal ganglion cell (RGC) types that send
visual information to the brain, and more than 10 polyaxonal amacrine cell (PAC) types that modulate RGC
activity over large areas. We will develop new methods to understand their role in natural vision. We will
leverage our large, unique database of recordings from macaque monkeys, the animal model closest to the
human, to direct our experiments with precious human tissue. This work is made possible by several technical
advances: novel large-scale high-density recordings from human donor retinas, novel machine-learning
methods for mining of similar large-scale recordings from macaque monkey retinas performed over the last 15
years, and novel analytical methods to identify, model and compare new cell types and their function in the two
species. Preliminary results in both species reveal a striking variety of new RGC and PAC types, some of
which are likely homologs, and others that may be unique to humans. We will pursue two aims: (1) identify
many novel RGC and PAC types in the macaque retina, probe their unusual light response properties, and
develop models that allow us to further probe their role in natural vision, and (2) identify and characterize many
RGC and PAC types in the human retina, and then use novel large-scale analysis methods to identify
homologous types in the macaque retina. At the conclusion of this work, we will have identified and thoroughly
characterized many of the most important visual pathways at the output of the human retina, developed and
tested models of their function in natural vision, quantitatively compared to homologs in the most important
animal model, and identified retinal cell types and visual signals that are likely unique to humans.

Public health relevance
Project Narrative The goal of the proposed work is to understand how the diverse cell types in the human retina process visual information and transmit it to the brain, and how this compares to the large existing body of work from the closest animal model. Using a collection of novel techniques, we are now able to study the functioning of retinas obtained from human donors. This work will make it possible to understand the function of the human retina in ways that were never before possible, with implications ranging from understanding human vision to diagnosing visual disorders and developing retinal implants to treat incurable blindness.